Core E: Data Management

PROJECT SUMMARY/ABSTRACT: Core E (Data Management Core)
The goal of the Data Management Core (Core E) is to support recruitment data activities, provide high-capacity
data storage and run large computational tasks for the READD-ADSP cores and projects. The core will: 1)
support and track demographics, cognitive testing results, pertinent medical history and history of cognitive
problems from the Ascertainment and Outreach Core (Core B), 2) manage phenotype and genomic data
produced by the Adjudication and Phenotype Harmonization (Core C) and Genomics and Biomarker (Cores D)
Cores, 3) support databases for phenotypes, genotype and biomarker data, analysis results (all Projects), and
annotations (Cores C, D and Projects), 4) perform imputation of genotyping data for analysis in Projects, 5)
provide cloud computing analysis support and optimization to Projects, and 6) provide server support for the
READD-ADSP website and dashboard. The final READD-ADSP resource, including data collected within this
application and future biomarker and whole genome sequencing, will create an invaluable resource for the
Alzheimer disease genomics research community. Identification of population specific genomic associations
facilitated by this resource will both increase our biological understanding of Alzheimer's disease and ensure
that therapeutic development will benefit all populations.